Endogenous Cannabinoids in Inflammatory Airway Disease

Abstract
This proposal details a two-year plan to prepare the candidate, Joshua M Levy, MD, MPH, for a career as an
independent translational investigator positioned to advance our understanding of asthma and allergic airway
disease. The proposed investigations focus on the role of endogenous cannabinoids as mediators of upper
and lower airway inflammation in Aspirin-exacerbated respiratory disease (AERD). AERD is clinically
characterized by moderate to severe asthma, nasal polyps and anaphylactoid reactions to aspirin and other
nonsteroidal anti-inflammatory drugs (NSAIDs). Aspirin challenge represents the gold-standard to diagnose
AERD, but is poorly utilized due to limited availability of specialized providers and concerns of adverse
reactions to the procedure. Therefore, up to 42% of patients with asthma and nasal polyps fail to receive an
accurate diagnosis of AERD, resulting in inadequate treatment marked by multiple sinus surgeries, irreversible
airway remodeling and an annual U.S. healthcare expenditure of >$4.5 billion. The candidate has identified
increased expression of the endogenous type-2 cannabinoid receptor in AERD nasal polyp epithelium, a novel
finding that is independent of tissue inflammation and holds potential to advance patient care via the
development of innovative diagnostic and treatment strategies. Employing an observational study design with
cellular and biochemical approaches, the candidate will test the hypotheses that endogenous cannabinoid
(endocannabinoid) dysregulation is associated with airway inflammation in AERD and represents a novel
target for diagnosis and drug discovery. These studies will advance our understanding of AERD while
developing both a biomarker screening panel and preclinical evidence lending support for the trial of
endocannabinoid-directed therapeutics in this disease. During the period of support the candidate will leverage
his clinical experience in the diagnosis and treatment of AERD, the regional referral patient base at his
institution's AERD Center, and his laboratory skills while further developing skills in clinical study design,
advanced biostatistics, team leadership, and scientific writing. These skills will enable his transition to
independence with the submission of R01 proposals during the second year of this award. Dr. Levy will work
collaborator Andrew A. White at Scripps Health, a national leader in the clinical study of AERD to further
support the feasibility of rapid study completion. Additional support in the form of continued mentorship will be
provided by David M. Guidot, MD, an expert in the translational study of lower airway disease in chronic
inflammatory states. Additionally, Dr. Levy has assembled a team of extraordinary PhD and physician
collaborators, including Drs. Michael H. Koval and Reneé H. Moore, who have committed their time and
resources to facilitate the successful completion of this study. Completion of this translational study will position
the candidate to secure independent NIH funding and establish himself as a physician-scientist with a focus on
clinical and translational studies of endogenous cannabinoids in AERD and other forms of asthma.

Public health relevance
Narrative Asthma is a common disease affecting up to 15% of the population of the United States, and approximately one in twelve adults with asthma develops life-threatening airway exacerbations following the ingestion of Aspirin or other similar over-the-counter medications. These patients with Aspirin-exacerbated respiratory disease (AERD) suffer from chronic sinus disease with nasal polyps, and often go undiagnosed and have limited treatment options. In this proposal we seek to understand recent findings that increased expression of endogenous cannabinoid receptors in AERD may provide new insights into the cause, diagnosis and treatment of this progressive disorder.